MEMBRANES OF THE DENTAL PATHOGEN STREPTOCOCCUS MUTANS

Project Summary. Streptococccus mutans is a ubiquitous oral bacterium and prominent etiologic agent of
human dental caries. Certain strains can also cause bacterial endocarditis and invade human coronary
epithelial cells. US health care costs associated with dental decay alone are over $64 billion annually. This
project addresses membrane protein insertion in S. mutans. A semi-permeable lipid bilayer membrane
encloses all cells and determines cellular function by dictating what can cross by virtue of proteins embedded
within differing lipid milieus. S. mutans shares features common to other bacterial membrane protein insertion
systems, and those of eukaryotic endoplasmic reticulum and organelles, but also exhibits unique properties.
S. mutans is becoming an established model for studying protein transport in Gram+ bacteria. All known
regulatory circuits and multiple virulence attributes of S. mutans stem from its membrane protein composition.
Biological membranes are ~50% protein by mass and membrane proteins represent most known drug targets.
Thus understanding S. mutans protein transport and insertion pathways will facilitate targeted therapy against
this and related pathogens. This project focuses on co-translational protein transport including YidC insertases
(bacteria, mitochondria, and chloroplasts), and the signal recognition particle (SRP) pathway conserved in all
living cells. We identified respective S. mutans YidC1, YidC2, and SRP substrates and identified four pathway
frameworks: canonical SRP pathway, autonomous YidC pathway, coordinated YidC2-SRP pathway, and an
SRP-independent pathway in which YidC1 interacts with the SecYEG translocon and an uncharacterized
protein called Jag. We also characterized the cardiolipin-rich lipidome of the S. mutans membrane and
showed the influence of lipid composition on membrane partitioning of specific components of the transport
machinery. In this renewal application we will identify interactions of protein components of the transport
machinery with anionic lipids using Martini22 coarse-grain molecular dynamic simulation in conjunction with
circular dichroism, solution NMR, and biolayer interferometry (SA1). We will also evaluate protein-protein
interactions in the context of varying lipid milieus by molecular dynamic simulation, blue-native polyacrylamide
gel electrophoresis, and will utilize solid state NMR to evaluate protein-protein contacts and structures of
protein pairs and oligomers. Findings will be validated using insertion of epitope-tagged substrates in vivo, and
in vitro transcription-translation-insertion assays with customized proteoliposomes (SA2). Lastly, membrane-
localized Jag is a predicted RNA binding protein (RBP). Mitochondrial membrane-localized RBPs have
recently been shown to chaperone specific mRNAs for coupled translation-insertion. jag and rnpA encoding
ribonuclease P are in the same operon as yidC1. Therefore we will also evaluate the roles of Jag and RnpA in
post-transcriptional regulation of yidC1, yidC2, and genes encoding relevant substrates (SA3).

Public health relevance
Project Narrative Streptococcus mutans is an oral bacterium and major global infectious agent that causes human dental caries, as well as bacterial endocarditis and atherosclerosis, with annual health care costs related to dental caries in the US alone exceeding 64 billion dollars. Multiple virulence properties of S. mutans stem from the way the organism inserts proteins into the lipid bilayer of the membrane, but the cellular machinery that transports these proteins is not completely understood. This research explains how proteins important for disease get into the membrane of S. mutans and other related pathogens.